Data Management Core

PROJECT SUMMARY
The MOVE Consortium seeks to accelerate the development of an HIV vaccine through an iterative framework
to design and test a matrix of complementary immunogens that reliably induce broad, durable immunity. Within
this collaborative, interdependent effort, the MOVE Consortium produces vast amounts of rapidly changing,
heterogeneous data, creating challenges in managing, tracking, and sharing data.
The goal of the Data Management and Bioinformatics Core is to promote the reuse and understanding of
the large, multidisciplinary multi-omics data we generate. We aim to release as much of our data and results
as possible, as quickly as possible, by managing, tracking, and monitoring all MOVE activities and data assets
and publishing them on our MOVE Data Portal, data.hivmove.org. To aid in the understanding of these data,
we will develop approaches to improve the accessibility and interpretability of our data through innovative
bioinformatics software and visualization tools. Lastly, we seek to engage with the community to promote the
adoption and adaptation of our data and tools and to proliferate FAIR-sharing best practices throughout the
research community.
To accomplish these objectives and support the overall mission of the MOVE Consortium, we have the following
three aims. First, we will develop reproducible pipelines for capturing data and metadata. Next, we will design
and implement a custom interactive data portal and API for sharing the data according to FAIR data practices
(findable, accessible, interoperable, reproducible). Lastly, we will develop tools in support of Projects 1 and 2,
the Animal Models Core, and the Structural Proteomics Core to accelerate the characterization of human
immunogenicity of Q23, identification of boosting immunogen candidates, and evaluation of delivery
mechanisms. These aims will promote the sharing and reuse of MOVE data, develop extendable and reusable
technologies and practices for data sharing, and build new analysis and visualization tools for immunological
data.